2022 Intermediate Filaments Gordon Research Conference and Seminar

Summary
Intermediate filament (IF) proteins are encoded by ≈65 distinct genes, placing them among the largest gene
families in humans. Members of the IF protein family not only serve as critical components of the cytoskeleton
and nucleoskeleton, but also act as sensors, modulators, and integrators of key structural and regulatory
proteins. Mutations in genes encoding IF proteins cause a wide range of diseases, including blistering skin
diseases, muscular dystrophy, cardiomyopathy, premature aging syndromes, and neurodegenerative
disorders. IFs and their abnormal assemblies are hallmarks of and important biomarkers for neurodegenerative
diseases, cancer, and aging. The first therapeutic interventions based on research on IF proteins are now
starting to benefit patients, yet many questions remain regarding both their basic functions and pathogenic
roles in disease. Given the diverse functions of IFs, their interactions with other cellular components, and their
disease relevance, close collaborations between basic researchers and clinical/translational investigators
spanning multiple disciplines are necessary to overcome current challenges in the field. Bringing together such
diverse scientists will provide new insights into the physiological function of IFs and enable developing novel
therapeutic approaches for IF-related diseases. Towards this goal, this application requests funds to support
the 2022 Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on IFs to be held at
Mount Snow, West Dover, VT, in June of 2022. We have organized a stimulating program of scientific sessions
in an environment that is conductive to concentrated discussion and debate to both established scientists and
young investigators/trainees from diverse backgrounds representing multiple disciplines. Aim 1 is to provide an
interdisciplinary forum for the discussion of cutting-edge research on IFs and their relationship to normal
cellular functions and disease. Aim 2 is to highlight novel scientific themes of IF research through seminar
sessions led by leaders in the field and relevant talks by investigators outside the field. Aim 3 is to promote
formal and informal scientific exchanges on IF biology between investigators across the entire career
spectrum, including senior, mid-career and early-stage scientists, postdoctoral researchers, and graduate
students. Graduate students and postdoctoral researchers will also be able to participate in the GRS
immediately prior to the GRC. The GRS is run solely by graduate students and postdoctoral researchers
studying IFs. To enhance interactions, each day of the GRC and GRS will provide numerous opportunities for
informal exchanges among participants, including shared meals, free afternoons, poster sessions, and evening
social times. The broad long-term objectives of the GRC and GRS are to grow the IF community, and to
provide complementary forums for the exchange of ideas among scientists at all career stages interested in
IFs, a family of proteins that are currently understudied despite their significant impact on many areas of public
health.

Public health relevance
Narrative Intermediate filaments (IFs) are a family of proteins required for cell shape, tissue organization, signal propagation, cell motility, DNA replication, transcription, microbial and viral infection, and inflammatory and other stress responses. IFs are key regulators of aging, and mutations in genes encoding IF proteins cause over 100 human diseases that affect all the major organs, including skin, skeletal muscle, bone, heart, brain, nerves, and the vasculature. The 2022 Ifs Gordon Research Conference and Seminar will bring together world class scientists from across the career spectrum to discuss recent discoveries in the field, with the goal to advance our understanding of biological systems and to translate this knowledge into new cures for human diseases.